Administrative Core: Clinical Research Center for the Improved Prevention, Diagnosis, and Treatment of Vocal Hyperfunction

Project Summary/Abstract
The Clinical Research Center for the Improved Prevention, Diagnosis, and Treatment of Vocal Hyperfunction
(VHCRC) brings together a multidisciplinary team of experienced investigators to pursue a comprehensive
program of research focused on hyperfunctional voice disorders. The VHCRC consists of four research projects,
an Administrative Core (Admin Core), and a Technology and Data Science Core (Tech Core). The research
program will be conducted primarily by a consortium of three institutions: (1) Massachusetts General Hospital
will serve are the lead/primary institution for the VHCRC and includes the Admin Core, Tech Core, and Project
1 (Identifying physical and behavioral factors and mechanisms to improve detection and phenotyping of vocal
hyperfunction) and Project 4 (Use of ambulatory biofeedback to improve behavioral treatment of vocal
hyperfunction); (2) Boston University will conduct Project 2 (Sensorimotor mechanisms of vocal hyperfunction);
and (3) Universidad Técnica Federico Santa María will conduct Project 3 (Modeling biomechanical, aero-
acoustic and auditory-motor control mechanisms of vocal hyperfunction). Additional institutions involved via
subcontracts include Boston Medical Center, University of Waterloo, Clarkson University, and Emory University.
The Admin Core will provide overall administrative support and direction for the entire VHCRC. It will be led by
the Program Director (PD) with assistance from an Administrative Coordinator. Duties performed by the Admin
Core include 1) performing all financial functions related to the operation of the VHCRC, 2) overseeing and
ensuring compliance with all human studies regulations, 3) submission of annual progress reports to NIH, 4)
scheduling and conducting regular meetings of all of the investigators participating in the VHCRC to optimize the
cohesion, integration, and efficiency of the research program, and 5) periodic comprehensive evaluation of the
VHCRC and its components. In terms of administrative structure, the PIs of the projects and Tech Core report
directly to the PD who has final authority in settling disputes or disagreements that cannot be resolved by
consensus. In addition to regular meetings of the entire research team, the PD and PIs of all projects and cores
(with selected consultants as deemed necessary) will meet annually with an Advisory Committee of leading
experts in areas related to VHCRC projects. This Advisory Committee will be actively involved in the evaluation
and planning process of the VHCRC, including evaluating the scientific progress and optimizing strategies to
meet the overall research goals over the course of the grant award.
The Admin Core is considered critical to the success of the VHCRC in achieving its overall long-term goal of
improving the prevention, diagnosis, and treatment of hyperfunctional voice disorders.